Influence of sleep on the hematopoietic niche and atherosclerosis during aging

Sleep is integral to health. Humans should be asleep for a third of their lives, yet we are becoming increasingly
sleep deprived. Poor or insufficient sleep increases the risk for a number of pathologies including
cardiovascular disease (CVD). Sleep, however, varies across an individual's lifetime — sleep time and quality
deteriorate in the elderly. Congruent with sleep deterioration, CVD risk increases with age. These observations
raise a fundamental question; does sleep disruption directly contribute to age-associated CVD? Here we will
explore the biological pathways that connect sleep, aging, and cardiovascular health. Recently, we
demonstrated that sleep fragmentation (SF) in mice augments hematopoietic stem and progenitor cell (HSPC)
proliferation in the bone marrow (BM), leading to monocytosis, neutrophillia, and larger atherosclerotic lesions.
We identified a neuro-immune communication axis whereby the sleep-regulating neuropeptide hypocretin
signals to the hematopoietic niche to regulate pre-neutrophils' production of the myeloid growth factor colony
stimulating factor-1. Here we build on our published findings and preliminary data to explore the hypothesis
that that sleep disruption advances the biological age of the hematopoietic niche and augments vascular
inflammation through epigenetic and senescent programs. We will explore this hypothesis using innovative
mouse models and technologies. Aim 1 interrogates the hematopoietic niche stromal compartment of young (3-
month-old) and aged (18-month-old) mice of both sexes exposed to 16 weeks of SF. We will identify ways in
which sleep shapes niche structure and organization and explore the function of endothelial cell senescence,
transcriptional landscape, and IL-6 signaling in these phenotypes. Aim 2 investigates hypocretin signaling in
the hematopoietic niche in young and aged mice of both sexes. Using innovative mouse models we will profile
hypocretin-producing and responsive cells in the BM and query their transcriptional and epigenetic programs.
Aim 3 moves from the BM to the vessel wall. We will investigate SF-induced atherogenesis in young and aged
Apoe-/- mice of both sexes. We will explore the role of vascular cell senescence and leukocyte dynamics in
atheromata growth and stability. Single cell technology will be used to identify cellular composition and
transcriptional landscapes. This program will apply state-of-the-art technologies to investigate systems-level
communication networks. Our interrogations into the hematopoietic niche, neuropeptide signaling in the BM,
and atherogenesis in the vessel wall will reveal the function of sleep in age-associated CVD and will fill crucial
knowledge gaps with direct clinical translation.

Public health relevance
Cardiovascular disease such as vascular atherosclerosis kills more people than any other disease worldwide. Recent work has shown that sleep controls inflammatory pathways leading to cardiovascular disease. Inflammatory cells are produced in the bone marrow by a process called hematopoiesis. In this project, we will investigate how sleep controls hematopoiesis in the bone marrow and inflammation in the vessel wall.